Physicochemical control of multilineage emergence

Project Summary
Human induced pluripotent stem cells (iPSCs) are unique in that they retain their ability to indefinitely self-renew
while maintaining the capacity to self-organize and differentiate into both embryonic and extraembryonic
lineages. iPSCs have emerged as a powerful tool to study human development, and disease, and have been
integrated with tissue engineering approaches for regenerative medicine applications. To fulfill the promise of
iPSC clinical utility, further investigation of the role of the stem cell niche in iPSC morphogenesis, lineage
specification, and functional maturation is needed. While organoid approaches have revolutionized our ability to
mimic organ-level function in a dish, they typically are comprised of cells from a single germ layer, missing critical
cues shared by surrounding populations including the microvasculature and stroma. In addition, organoids are
generated in ill-defined matrices such as Matrigel, which suffers from batch-to-batch variation, and limited
tunability. To this end, we propose using micropatterned induced gastrulation models to better understand how
paracrine and mechanical cues guide primitive stem cell fate. In addition, by leveraging assembloid technologies,
synthetic extracellular matrix mimics, and dynamic microfluidic culture, we aim to better understand multi-germ
layer interactions during tissue specification. Finally, we propose that improved iPSC derivatives can be used
to better understand patient-specific differences in metabolic disorders. Collectively, we propose that using an
integrative approach will permit iPSCs to be a powerful testbed for studying developmental biology and disease
processes.

Public health relevance
Project Narrative. The goal of this project is to use human induced pluripotent stem cells, micropatterned culture, synthetic biomaterial scaffolds, and microfluidics, to recreate the dynamic microenvironmental cues that coax tissue self- assembly and maturation. We anticipate that this holistic approach will enhance our understanding of multi- germ layer communication in lineage specification, as well as the role of mechanical and chemical cues in directing stem cell fate. Collectively, these approaches will build a framework for elucidating the mechanisms of human development and improve stem cell models of morphogenesis and disease.